BRAIN CONNECTS: The center for Large-scale Imaging of Neural Circuits (LINC)

Project summary: This project will develop and validate a comprehensive toolset of novel technologies for
imaging axonal projections across scales, and will deploy this toolset to map a complex system of cortico-
subcortical projections in the macaque and human brain. We will combine the complementary strengths of
three innovative microscopy techniques. First, polarization-sensitive optical coherence tomography (PS-OCT)
will provide label-free, undistorted imaging of axonal orientations at the scale of microscopic fascicles, allowing
us to follow fascicles across the brain without the need for axon segmentation. Second, whole-mount light-
sheet microscopy (LSM) of cleared and immunolabeled sections will allow us to image fascicles at the sub-
micron scale, resolving individual axons. Third, hierarchical phase-contrast tomography (HiP-CT) will allow us
to image both the axons and their micro-environment, at a range of scales from a few microns down to sub-
micron. We will scale these three microscopy techniques up to image a large sub-volume of the brain (up to
two thirds of a hemisphere) that contains subcortical projections of the motor, premotor, and prefrontal cortex.
In the macaque brains, fluorescent tracer injections will allow direct validation of our novel microscopy
techniques. In combination with an extensive collection of prior tracer injections, the macaque data will also
provide the topographic organizational rules of fibers in cortico-subcortical bundles, which we will then use to
validate our novel microscopy techniques in human brains. In both macaque and human specimens, we will
also collect extensive, cutting-edge, whole-brain diffusion MRI data, which will provide the link to non-invasive
neuroimaging. The unprecedented datasets generated by our project will enable research discovery in two use
cases. In the first use case, we will annotate projections of the motor, premotor, and prefrontal cortex to the
subthalamic nucleus (STN). We will use them to advance our understanding of circuits associated with clinical
improvements in four diseases that are treated with deep-brain stimulation in neighboring subzones of the
STN: dystonia, Tourette’s syndrome, Parkinson’s disease, and obsessive-compulsive disorder. In the second
use case, we will investigate the mapping from the axonal orientations and microstructural features obtained
from the microscopy data to dMRI signals acquired in the same brains. In addition to the unprecedented
datasets and the two use cases described above, this project will generate state-of-the-art pipelines for pre-
processing, co-registration, axon segmentation, tractography, and quantification, across the scales spanned by
the acquired data. We will develop a novel platform for sharing the microscopy, tracer, and MRI data with the
research community. This will go well beyond a static data repository, allowing the user to interact with the data
remotely and providing a “validation engine” for testing neuroimaging software tools against the gold standard
post mortem data collected by this project. If successful, this project will generate a scalable and validated
toolset for imaging connectional anatomy, with a direct link it to its applications in the study of human disease.

Public health relevance
Project narrative: This project will generate connectional diagrams of the monkey and human brain at unprecedented resolutions. These diagrams will be linked both to the neuroanatomic literature and to in vivo neuroimaging techniques, bridging between the rigor of the former and the clinical relevance of the latter. The data to be generated by this project will advance our understanding of brain circuits that are implicated in motor and psychiatric disorders, and that are targeted by deep-brain stimulation to treat these disorders.